Chicago Center on Musculoskeletal Pain P30

This proposal is a supplement to Parent Grant P30AR079206, “Chicago Center on Musculoskeletal Pain
(C-COMP)” (2021-2026), which aims to establish a resource-based center to foster and support research and
training aimed at understanding the mechanisms underlying pain associated with musculoskeletal (MSK) and
rheumatic diseases, with the ultimate goal of better managing and preventing it. The long-term broad objectives
of C-COMP are: (1) To foster high-quality, innovative, standardized, focused research on the topic of pain in
rheumatic and MSK diseases; (2) To promote translationally relevant cross-disciplinary research, based on
collaborations between MSK researchers and pain researchers/neuroscientists; and (3) To expand the Research
Community in this area, and increase extramural funding for this understudied topic.
Pilot funding for innovative and meritorious proposals is a key element of C-COMP’s Enrichment
Program’s role in driving the field forward by advancing high quality research in the area of musculoskeletal pain,
as well as expanding the field of research. This supplement directly addresses the NOSI Goal B: “Expand
rheumatic, skin, and musculoskeletal disease pain research capacity (cohorts, technologies or data) beyond
current research base/collaborators”, by seeking to expand the number of pilot grants to be awarded in the next
cycle from 4 to 6 awards of $25K each. Indirectly, successful pilot grants will contribute to Goal A: “Generate
supporting evidence towards a future innovative study or new scientific direction in pain research in rheumatic,
skin, and musculoskeletal diseases”.
We propose to expand the pilot funding by $50K, so that we can award two more grants – for a total of 6
awards in cycle 2. All pilot grant awardees from both cycles will be invited to Chicago to participate in the first C-
COMP Annual Symposium on December 4 2023.
We anticipate this approach will increase the reach and effectiveness of C-COMP and produce a longterm
beneficial impact on research into pain associated with rheumatic and musculoskeletal diseases.

Public health relevance
The supplement to P30AR079206, “Chicago Center on Musculoskeletal Pain (C-COMP)” (2021-2026) aims to expand funding for pilot grants. We aim to award two additional grants, for a total of six $25K awards in cycle 2. All pilot grant awardees will be invited to participate in the first C-COMP Annual Symposium (12-04-2023).